Data Management and Statistical Core

REVISED ABSTRACT:
Data Management and Statistical Core: Project Summary –2P30AG066530-06 (5767)
The overall objective of the Data Management and Statistical Core (DMSC) is to provide high quality services and resources to the Administrative, Clinical, Neuropathology, Biomarker, Imaging, and ORE Cores, the Research Education Component (REC), and ADRC faculty (including investigators involved in ADRC projects, development projects, and ADRC-affiliated investigators). The DMSC resources will provide an informatics and statistics environment to support cutting-edge dementia research both locally and nationally. There are three aims to this Core: 1) Data management. Focused on the provision of F.A.I.R. data management framework for ADRC-related research This effort will be built upon a unified ADRC archive that houses and integrates all ADRD research projects and programs at USC. 2) Program coordination with national efforts ensuring timely and accurate data entry to NCRAD, ADGC, SCAN, CLARiTI and GAAIN (Global Alzheimer’s Association Interactive Network), among others. 3) Biostatistical support in the design, coordination and analysis of ADRC-related projects, including development projects supporting the REC, design of clinical studies and trials, integration and analysis of multimodal data, and support for data interpretation and manuscript preparation. 4) Education & training (in concert with the ORE Core and REC) via practical and didactic experiences on relevant study designs, statistical models, and informatics concepts and practices to trainees and investigators involved in dementia-related research. Finally, we will provide communications and documentation via the ADRC website.